Translational Training in Respiratory Disease and Repair

PROJECT SUMMARY
Our Translational Training in Respiratory Disease and Repair T32 seeks to train the next generation of basic,
translational and clinician scientists capable of working together to advance respiratory medicine toward
approaches that fully restore respiratory function in the setting of disease and dysfunction. We request support
for 5 postdoctoral trainees who will be mentored by an interdisciplinary and highly collaborative faculty of 26
individuals spanning basic (Physiology and Biomedical Engineering, Biochemistry and Molecular Biology) and
clinical (Anesthesiology, Pulmonary Medicine, Allergy, Cardiology, Surgery, Radiology) departments and
divisions within the Mayo Clinic College of Medicine and Science. Research and training conducted under this
program will span basic to clinical aspects of respiratory biology, physiology, and medicine. The basic research
thrust will train mentees to identify novel targets and approaches to defend, repair and regenerate respiratory
function in the setting of disease and dysfunction. A translational thrust focused on technology development
and therapeutic approaches will prepare trainees to generate novel tools and techniques needed to break
through current barriers limiting our understanding of, and capacity to reverse, acute and chronic respiratory
conditions. The clinical research thrust will bridge behavioral, clinical and translational studies and will focus
trainees on the unmet needs of patients while providing them with rich access to clinical data and
biospecimens. It will also allow trainees to experience and/or participate firsthand in implementation of novel
findings (technological or therapeutic) into clinical practice. Cross-cutting themes interwoven with these
programs will include Respiratory Biology Across the Lifespan spanning neonatal diseases and lung
development to aging-related disease and functional decline, and Human Disease Modeling which will develop
novel approaches to study living human cells and tissues as essential tools for bridging bench to bedside. The
resulting T32 program will combine exceptional physical resources, a rich and collaborative intellectual
environment, and an interdisciplinary and translational emphasis to train the next generation of scientists and
clinicians to tackle the most challenging unmet needs in respiratory disease and repair.

Public health relevance
PROJECT NARRATIVE Chronic respiratory diseases and dysfunction lead to shortened lifespans and compromised health for a large population in the US and globally. Interventions that reverse structural and functional lung decline are desperately needed, but frustratingly out of reach, in large part due to the complexity of these challenges. Our Translational Training in Respiratory Disease and Repair program seeks to train a new generation of scientists and clinicians to work together in teams to tackle the most challenging unmet needs in respiratory disease and repair using a patient-centered approach.